LONGITUDINAL LANGUAGE

The objective of this component project is to contribute to knowledge concerning communicative development in children with retardation being reared at home and compare their progress to that of typically-developing children using data from two methodologically identical longitudinal studies that observed the children's unstructured interactions with their families at home. Proposed is continued collection of follow-up data from the 11 children with Down syndrome, and its analysis for inclusion in a book summarizing the findings from the longitudinal study as a basis for recommendations to parents and practitioners. Follow-up visits are to be made once a year. The child's language is tape recorded and information up-dated by interviewing the parents. Language data is analyzed and merged with prior data to project the trajectory of each child's language development.